Preclinical Assessment of a Compliance Matched Biopolymer Vascular Graft

PROJECT ABSTRACT
Cardiovascular diseases represent the leading cause of death worldwide and are currently responsible for 32%
of all reported deaths before the start of the COVID-19 pandemic. The increase in cardiovascular disease
prominence has placed increasing levels of demand for cardiac bypass grafting (CABG), which is now the
most common cardiac surgery in the world. Despite CABG interventions with autologous tissues are viewed as
one of the most effective treatment options, their failure of rate remains as high as 42.8%, with only 50% to
60% maintaining patency after 10 years. Vascular engineering research has sought to develop tissue
engineered vascular grafts (TEVG) in the form of acellular or cellularized constructs as an alternative solution.
Despite decades of research advancements, very few TEVGs have reached clinical studies, and there are no
clinically approved TEVGs currently in use. Here we seek to advance our understanding of how TEVGs are
infiltrated by the host’s cells when stimulated by three different isoforms of the protein Transforming Growth
Factor Beta, and the impact this treatment can have on cellular remodeling of the TEVGs.
Aim 1: Investigate native vascular tissue stromal cell migration onto and proliferation within a TEVG
that is compliance matched and TGFβ isoform loaded in a 3D culture system. We will test the hypothesis
that compliance matched TEVGs containing TGFβ2 loaded microparticles can modulate the rates of explanted
native vascular tissue cellular migration and proliferation onto an adjoined TEVG at significantly higher levels
than delivery of two alternative TGFβ isoforms utilizing a 3D culture system. Native rat arterial tissues will be
canulated and placed into the 3D culture system adjoined to a compliance matched TEVGs. The acellular
TEVGs will initially be manufactured to carry PLGA microparticles (MPs) loaded with TGFβ isoforms (TGFβ-1,
-2, -3, respectively) to provide a controlled release of TGFβ from the intimal layer of the TEVGs. We will
assess early and late term cellular migration and proliferation onto the TEVG scaffolds as a function of culture
time and TGFβ isoform release across a selection of release rates and dosages. We will quantify these results
using multiphoton intravital imaging of the specialized 3D biaxial TEVG culture system.
Aim 2: Assess the cellular remodeling of the compliance matched TGFβ isoform loaded TEVGs
through intravital 2-photon imaging. To investigate the subsequent ECM remodeling of the compliance
matched TEVGs carrying TGFβ isoform loaded MPs in 3D culture, we will utilize intravital imaging of explanted
native rat abdominal aortas adjoined to TEVGs in culture as before. In this supplemental aim, we will utilize the
2-photon imaging system to quantify ECM remodeling via collagen/elastin content though second harmonic
generation (SHG, collagens) and 2-photon excited fluorescence (2PEF, elastin) signals. We will assess
scaffold matrix remodeling by relative SHG and 2PEF levels as a function of culture time and the respective
TGFβ isoform delivered.
Aim 3: Investigate the impact of progressive biaxial biomechanical stimulation of the TGFβ isoform
loaded TEVGs by assessing cellular migration, proliferation, and remodeling of the TEVGs by
infiltrating stromal cells. We will utilize another feature of our custom-built bioreactors (biaxial biomechanical
loading) to impose controlled pulsatile pressures and axial stretches upon the TEVGs to determine if this
biomechanical stimulation synergizes with the TGFβ isoform delivery to enhance cellular activity. As before,
the native rat aorta tissues will be adjoined to the TEVGs, this time exposed to a selection of progressive
biaxial biomechanical conditioning scenarios. Cellular migration, proliferation, and remodeling of the TEVGs
will be assessed with our intravital 2-photon intravital imaging system as before, and TEVG remodeling will be
determined by the relative SHG and SPEF signal generation at various locations throughout the scaffolds as
before. We will assess these measures as a function of culture time and levels of biaxial biomechanical loading
in combination with TGFβ isoform delivery to determine how each uniquely impacts cellular remodeling
outcomes.

Public health relevance
PROJECT NARRATIVE Heart disease number one killer of women and men in the United States, yet no small diameter tissue engineered vascular grafts have effectively treat this disease. Although impregnating vascular grafts with Transforming Growth Factor Beta 2 (TGFB2) has been utilized to enhance vascular smooth muscle cell migration and proliferation, it remains unclear whether other TGFB protein isoforms, such as TGFB1 and TGFB3, have unique effects upon the cellular matrix remodeling and mechanical properties of the grafts. This proposal seeks to utilize a 3D culture system and multiphoton imaging to assess how various isoforms of TGFB impact the cellular remodeling and biomechanical responsiveness of tissue engineered vascular grafts.